Engineer A Chemogenetic Toolbox for Unraveling Complex Signaling Networks

PROJECT SUMMARY
Cancer remains a global health challenge despite significant advancements in diagnosis and treatment. In the
past two decades, immunotherapy has dramatically changed the landscape of cancer treatment, with immune
checkpoint inhibitors (ICIs) targeting PD-1/PD-L1 and CTLA-4/B7-1 showing notable success. However, these
therapies benefit only a subset of patients, underscoring the need to explore additional immune regulatory
mechanisms. The T cell immunoglobulin and ITIM domain (TIGIT) has been identified as another promising
checkpoint for immunotherapy, with preclinical studies showing potential. However, clinical trials have revealed
that anti-TIGIT monotherapy offers limited benefits for patients with advanced solid tumors. The intricate network
of TIGIT signaling, characterized by its extensive crosstalk and interaction with other co-inhibitory and co-
stimulatory pathways, suggests that targeting TIGIT alongside other pathways using bi- or trispecific antibodies
might enhance antitumor efficacy. The primary challenge in leveraging this approach is target determination due
to the complexity of TIGIT network, which is influenced by a delicate balance of various components, each
contributing differently to immune regulation. Developing a quantitative model that accurately reflects the role of
each element within the TIGIT pathways as well as their collective impact is crucial for devising effective targeted
therapy combinations. However, the field faces substantial technical hurdles, especially in achieving precise,
noninvasive, and simultaneous control of multiple protein components in T cells to assess their collective impact
on immune suppression. To address this, we propose the development of a chemogenetic toolbox that allows
for the controlled expression of multiple proteins. This toolbox will allow us to dissect the intricate immune
suppression mediated by the diverse elements in the TIGIT network. This strategy utilizes destabilization
domains (DDs) which, upon binding to specific small molecules (SMs), can modulate protein levels in a dose-
dependent manner. Despite the availability of some DD:SM pairs, their application is limited by issues such as
interference with endogenous systems, poor SM permeability, and lack of orthogonality. To address this and to
study TIGIT signaling, our project is structured around three main objectives: (1) engineering new and orthogonal
DD:SM pairs through molecular docking and advanced protein engineering to overcome existing limitations (Aim
1), (2) developing a high-throughput assay to unravel the complex immune inhibition orchestrated by various
components within the TIGIT network and to establish a quantitative model (Aim 2), and (3) Generating bispecific
antibodies that target critical elements within the TIGIT network to augment the immune response (Aim 3).
Through this research, we aim to unlock new insights into TIGIT signaling and establish a solid framework for
assessing the most effective therapeutic combinations, ultimately enhancing the arsenal of immunotherapy, and
potentially improving outcomes for cancer patients.

Public health relevance
PROJECT NARRATIVE Immunotherapy, notably with agents targeting PD-1/PD-L1 and CTLA-4/B7-1, has significantly advanced cancer treatment, yet its efficacy is restricted to a subset of patients, highlighting the need to explore additional immune targets such as TIGIT signaling. To address the limited effectiveness of anti-TIGIT monotherapy in clinical trials, we propose to create an innovative chemogenetic toolbox for the detailed analysis of TIGIT interactions or crosstalk and to develop a quantitative model that accurately captures both individual and collective pathway dynamics. This endeavor will shed light on the complex interplay and crosstalk within the TIGIT signaling network, offering a strategic framework to identify highly effective therapeutic target combinations and significantly expand the capabilities of cancer immunotherapy.